Develop Pilot Program for Asymptomatic COVID-19 Testing for NCI-Frederick Staff

Test samples will be collected by the contractor from asymptomatic volunteers and will be open to all government and contractor staff. The samples will be transported the NIH Clinical Center for analysis. The scope of this effort includes all labor, equipment, logistics, materials and supplies, and management of test records. The collection, storage, and transportation of clinical samples will be in accordance with the NIH Clinical Center protocols.